Developing a topical beta blocker formulation as a targeted therapeutic for infantile hemangioma

PROJECT SUMMARY / ABSTRACT
This application is responsive to the stated goals of the NHLBI Branch: to understand and promote health and
resilience and enable the translation of discoveries from basic science into clinical practices. Arkayli Biopharma
is developing a novel topical therapeutic for infantile hemangioma (IH) formulated for superior efficacy, safety,
and convenience compared to the solitary FDA-approved oral treatment. Infantile hemangioma (IH) is a blood
vessel tumor that affects around 170,000 infants annually in the United States. These benign vascular tumors
are barely evident at birth but grow rapidly in the first few weeks-months of life and can interfere with breathing
and vision, however, the most common complications are ulceration and permanent scarring. Infantile
hemangiomas are composed of proliferating endothelial-like cells, and treatment is aimed at inhibiting vascular
proliferation before complications arise. Although oral β blockers have become a standard first-line therapy for
IH, there remains a crucial need to enhance safety by reducing systemic exposure to β blocking agents. Some
physicians and parents hesitate to start β blockers because of the known (respiratory, metabolic, and
cardiovascular) and unknown long-term risks related to neurocognitive function. Our novel formulation leverages
soft drug design to create a safer medication with an enhanced therapeutic index by incorporating metabolism
considerations into the drug design process. Given the systemic drug exposure associated with administration
of both oral and topical β blockers, our goal is to address this challenge by developing a topical formulation that
undergoes rapid metabolism in the blood, within minutes after leaving the skin. Consequently, this formulation
will result in negligible accumulation of active drug in the blood and minimal systemic β-adrenergic antagonism,
making it safer than existing products on the market. By combining a high local concentration of the active agent
with low systemic exposure, our product will maximize therapeutic efficacy while minimizing adverse
cardiovascular, metabolic, respiratory, and neurological effects in young infants. We have robust in-vitro data
validating our hypothesis, and preliminary animal studies demonstrating no systemic β-adrenergic antagonism
when our product is applied topically. In this Phase I project, Arkayli Biopharma will partner with the University
of Wisconsin to complete pivotal research and development studies needed to submit an Investigational New
Drug Application. Aim 1: Evaluate the effects of ARK 001 formulation on in-vitro endothelial cell tube formation,
proliferation, and invasion. Aim 2: Conduct enabling nonclinical animal pharmacokinetic and toxicity studies.
The outcomes of this research will inform study design and dose selection for the definitive Good Laboratory
Practices (GLP) toxicology study in juvenile animals. The long-term overarching goal is to address a significant
unmet commercial demand by creating a novel formulation of a topical treatment for infantile hemangiomas (IH).
This formulation will be highly effective, user-friendly, and notably safer than existing products on the market.

Public health relevance
PROJECT NARRATIVE Arkayli Biopharma is developing a novel treatment for infantile hemangioma. With a commitment to innovation and patient safety, we have harnessed soft drug design principles to create a topical formulation that metabolizes rapidly upon skin permeation, thereby reducing undesirable side effects. The goal of this project is advance development of a topical formulation that aims to not only enhances efficacy but also prioritizes safety, particularly for vulnerable populations such as young infants.